GONADAL PHYSIOLOGY AND SOMATOTROPH FUNCTION IN AIDS

This study will be used to define gonadal and GH physiology in men with AIDS wasting syndrome and to establish he metabolic consequences of hypogonadism in this population of patients.